Social experience dependent cellular plasticity of brain circuits

Summary
Social animals often compete for dominance through agonistic interactions to form social hierarchies. As social
relationships mature, the behavior patterns of members diverge according to social rank. Although we know that
the behavioral differences that emerge between dominant and subordinate animals are rooted in physiological
adaptions, our understanding of the morphological and functional plasticity the nervous system undergoes
remains poorly understood. This proposal tackles this issue by investigating the neural bases of social
dominance and its impact on behavior using zebrafish as a model organism. We focus on two brain nuclei
involved in social regulation: The diencephalic dopaminergic posterior tuberculum nucleus (PTN) regulates
motivation, aggression, and spinal motor circuits, and secondly, the thalamic parathyroid nucleus which regulates
prosocial behavior and processing of visual information. Our objective is to examine the cellular mechanisms of
how social dominance induces morphological and functional plasticity of the PTN and how status affects the
thalamic parathyroid system and its regulation of visual information. We will leverage the technical biological
advantages zebrafish provides to address the following aims: In aim 1, we will examine how social dominance
affects the morphological architecture of the PTN and its synaptic interconnectivity during social rise and fall. In
aim 2, we will examine how social dominance induces status-dependent functional differences in PTN electrical
excitability, calcium dynamics and biochemical activities. In aim 3, we will examine how social status affects the
morphological and functional architecture of the parathyroid nucleus, its morphological interactions with the
visual system and modulation of motor behavior. Results from this study will improve our understanding of how
social dominance influences decision-making networks and their regulation of motivation and aggression, the
principles of which may be applicable to other social species.

Public health relevance
Project Narrative Social dominance is common among social species. The aim of this project is to investigate the neurophysiology of social dominance and how aggression affects brain function and behavior. Results from this project will improve our understanding of how social dominance induces morphological and functional plasticity of specific brain nuclei involved in sensory processing and regulation of spinal motor behavior.